T cell regulation of pathogenic B cell in systemic autoimmunity

E J J ? and IL ? We

Public health relevance
NARRATIVE The manipulation of genes that define T cell and B cell populations will have functional consequences in progression of disease and disease enhancing antibodies. This study explores regulation of these cells by their gene profiles and may provide new targets for future therapeutics in autoimmunity.